Maternal Positive Affect Socialization and Child Neural Reward Response

Abstract
Reward-related brain function is consistently linked to greater motivation, pleasure, and goal-directed behavior
and lower risk for depression across the lifespan. Healthy neural reward response supports socioemotional
development, particularly during the preschool years as self-regulatory skills and child reward-related brain
function are rapidly developing in the context of the caregiving environment. Maternal socialization of positive
emotion is one important influence on early reward circuitry development. Mothers with depression are more
likely to discourage (and less likely to encourage) child positive emotions compared to healthy mothers, which
may contribute to early neural reward alterations in their children. Characterizing mechanisms of influence of
maternal socialization on child neural reward response and positive emotion during the preschool years is a
critical window of opportunity when parents have a large influence on child socioemotional development.
Importantly, maternal behavior is amenable to change by training parents on emotion coaching, and these
maternal behavior changes may result in direct and immediate changes in child neural reward function. Thus,
the overarching aim of this proposal is to use a mechanistic trial design to experimentally test the hypothesis
that maternal encouragement of child positive emotion will lead to in-vivo increases in child neural reward
response. Event-related potentials (ERPs) are uniquely suited to non-invasively assess in-vivo, fast-occurring
changes in child reward response during parent-child interactions, including reward positivity (RewP), and the
late positive potential (LPP) amplitudes. Toward this aim, we will randomize 180 mothers with clinically
significant depression symptoms and their 4- to 6-year-old children (50% female) to receive either 3 control
sessions or 3 positive emotion coaching modules from the Parent-Child Interaction Therapy-Emotion
Development (PCIT-ED, which trains mothers on how to encourage positive emotion in their young children.
Children will complete reward tasks at pre- and post-coaching, while neural reward response is assessed via
ERP (RewP and LPP) with their mothers present allowing for in-vivo assessment of maternal behavior. At both
timepoints, we will assess child neural reward response and mothers’ self-reported maternal socialization
behaviors. Understanding how disrupted neural reward responding develops in the preschool years is critical
for the promotion of child emotional wellness and can be directly used to develop preventive interventions
tailored to preschool age children at familial risk for depression.

Public health relevance
Project Narrative The preschool years are a sensitive period for the development of self-regulatory skills and reward-related brain activity that support socioemotional development. Maternal socialization of positive emotion is one important influence on development of reward-related brain activity in children, both of which can be impaired by maternal depression. To better understand how reward-related brain activity develops in the context of parenting, we will examine how maternal coaching of positive emotion in children of depressed mothers influences in-the-moment reward-related brain response.